Regulation of intestinal stem cell state by ID3

PROJECT SUMMARY
Stemness is a functional cellular attribute defined by properties of multipotency (the ability to produce all
differentiated cell types in a tissue) and self-renewal (the ability to produce new stem cells). In adult epithelial
tissues, stemness can exist in: (1) dedicated stem cells occupying a defined niche, and (2) differentiated cells
that exhibit plasticity to drive regeneration following injury. Stem cells must balance self-renewal with
differentiation, and differentiated cells must balance lineage specific identity with plasticity to participate in
regenerative responses. My lab is interested in understanding how chromatin modifications and their associated
enzymes interact with site-specific transcription factors (TFs) to establish cell identities while simultaneously
facilitating alternative cell fates. We focus on intestinal stem cells (ISCs), which drive the renewal of the intestinal
epithelium approximately once a week throughout adult life, as a model system. Over the next five years, my
research program will explore how TFs and chromatin modifying enzymes contribute to an exit from the
stem cell state as ISC differentiate. Current models propose that rapid differentiation and plasticity in the
intestinal epithelium is regulated by chromatin landscapes that are highly similar across all intestinal epithelial
cell types, regardless of differentiation stage. Recent studies in my lab have challenged this model using a
Sox9EGFP mouse model that allows us to isolate ISCs, progenitors, and differentiated cells with a single reporter
transgene. We quantified changes in chromatin accessibility and 5-hydroxymethylcytosine and identified
significant chromatin dynamics at genomic loci consistent with enhancers. Our analyses identified novel
candidate TF-chromatin interactions and raise exciting questions about the importance of chromatin regulation
in adult epithelial stem cells. Our future research will build on this progress to understand: (1) how stem cell-
associated chromatin is decommissioned by TFs in differentiation, (2) how lineage-specific regulatory programs
are “primed” in ISCs, and (3) how chromatin modifying enzymes bridge regulation of self-renewal and
differentiation. The approach proposed here will establish a long-term research program, with broad potential to
expand into studies of plasticity/de-differentiation, chromatin regulation of epithelial responses to environmental
challenges, and development. Our goal is to pursue a basic mechanistic understanding of chromatin regulation
in stemness that will have foundational relevance to human health and disease, including epithelial responses
to inflammation, infection, injury, aging, and tumorigenesis.

Public health relevance
PROJECT NARRATIVE Adult stem cell function is defined by multipotency, self-renewal, and plasticity, and is required for homeostasis and regeneration in epithelial tissues. The parent project aims to understand how stem cell function is genetically regulated by dynamic chromatin landscapes, including how cells can be “primed” to adopt alternative cell fates via differentiation and de-differentiation. This administrative supplement request is to support an undergraduate summer research experience for Mr. Gurel Ari, who will work toward the goals of the parent award by studying the functional role of Id3 in intestinal stem cell differentiation.